Multimodal Characterization of the Role of Circular RNAs in Alzheimer's Disease

Abstract
Transcriptomic studies in clinical and biomedical research have mainly focused on changes in linear transcripts
to provide knowledge of the genes and co-expression networks implicated in the disease. However, very little is
known about the role of circular RNAs (circRNAs) in Alzheimer's disease (AD). CircRNAs are a novel category
of non-coding RNAs derived from the back-splicing and covalent joining of pre-mRNA exons and introns. We
recently performed a transcriptome-wide analysis of circRNA differential expression in the brain cortex from more
than 621 brain samples from two independent and large cohorts of late-onset sporadic AD cases and
neuropathology-free individuals. We identified specific circRNAs, including circHOMER1, associated with AD
risk and neuropathological traits. This project will use brain tissue to identify additional brain circRNAs implicated
in AD from a cohort that is four-fold larger than the cohort in our previous study. We also plan to investigate
differentially expressed blood circRNAs in AD cases compared with controls to determine their biomarker utility
for creating new prediction models. We will establish a framework for in vitro and in vivo functional
characterization of the role of circRNAs in AD. As proof of principle, we will start by defining the role of
circHOMER1 in AD-related gene expression and related cellular phenotypes. We have found that circHOMER1
is highly expressed in induced pluripotent stem cell (iPSC)-derived neurons. We will use CRISPR/Cas9 to knock
down circHOMER1 as well as use circHOMER1 overexpression (OE) in iPSC-derived neurons from isogenic
controls and AD patient-derived neuronal cultures from pathogenic mutation carriers of APP, PSEN1, PSEN2,
and MAPT genes. To determine whether circHomer1 accelerate/increase AD-related pathology in vivo, we will
generate circHomer1-knockout transgenic mice and cross them with 5XFAD and MAPT-P301S mice. We will
also use AAV2/9-mediated circHomer1 OE in the cortex and hippocampus of 5XFAD and MAPT-P301S mice.
We recently found that seven-month-old 5XFAD mice display significant reductions of circHomer1 expression,
similar to the postmortem brains of AD patients. We will restore circHomer1 levels in the hippocampus and cortex
of 5XFAD and P301S mice using AAV2/9 vectors. This proposal will be the first to systematically analyze the
role of brain and blood circRNAs in AD and to perform in vitro and in vivo functional studies to characterize the
role of circRNAs in AD.

Public health relevance
Narrative Alzheimer's disease (AD) results from complex interactions of risk factors that cause pleiotropic changes in molecular networks linking a host of biological processes. A variety of genetic factors contribute to risk with varying degrees of penetrance. It is not understood how the transcriptomic and molecular changes are organized into networks and how the implicated pathways are modulated in AD. Brain transcriptomic studies have helped identify novel genes and networks involved in AD, but most of them focus on linear transcripts. This proposal will systematically identify additional circRNAs implicated in AD and functionally characterize circHOMER1, which has consistently been associated with AD risk.